Investigating the molecular mechanisms of asymmetric histone incorporation during DNA replication

Asymmetrically dividing adult stem cells, which divide to create both a self-renewing stem cell and a differentiating
daughter cell, play a crucial role in maintaining tissue homeostasis in multicellular organisms. It is well understood in
most cell types that epigenetic mechanisms regulate gene expression and thereby govern cell fate. Yet, it largely remains a
mystery how the two daughter cells generated during the asymmetric division of adult stem cells go on to acquire different
epigenomes. The lab previously discovered that histones, key carriers of epigenetic information, are segregated
asymmetrically during the asymmetric division of male Drosophila Germline Stem Cells (GSC). In this process old
histones are retained in the GSC while the differentiating cell inherits newly synthesized histones, suggesting that this
pathway could maintain epigenetic information in the GSC while priming the differentiating daughter cell to acquire new
epigenetic information during differentiation. Recently, we found that this process is mechanistically underlied by a two-
step process in which histones are first asymmetrically deposited on sister chromatids during DNA replication before
being differentially recognized and segregated during mitosis. During replication this asymmetry is primarily achieved by
incorporating old histones on the leading strand while the lagging strand later incorporates new histones. The finding that
asymmetric histone inheritance is driven by DNA replication opens the exciting possibility that DNA replication plays
unappreciated roles in patterning cell fate. However, the precise molecular mechanism by which histones are
asymmetrically incorporated on sister chromatids remains unclear.
Here I propose that the asymmetry in histone incorporation during replication in GSCs is driven by enhancing the inherent
asymmetry of DNA replication. I have found preliminary evidence that protein levels of RPA and lagging strand
polymerases DNA Polα and DNA Polδ may drive the asymmetry in this process. I propose testing further manipulating
the levels of these proteins using a series of approaches to alter the levels of these proteins using genetic and biochemical
approaches. I plan to read out the effects of these manipulations using superresolution imaging of chromatin fibers to gain
single molecule resolution of replication coupled nucleosome assembly. Further, I propose the novel hypothesis that the
altered levels of these proteins may drive the histone inheritance asymmetry by decoupling lagging strand synthesis from
replication fork progression. To explicitly test this model I plan to couple chromatin fibers with biochemical
manipulations of cell cycle progression to directly measure replication timing after fork progression for the leading and
lagging strand. Finally, using a sequencing-based approach I will assay whether histone incorporation also displays local
differences throughout the genome. The results of this study stand to dramatically improve our understanding not only of
DNA replication and epigenetics but could also provide a whole new framework to think about stem cell biology and cell
fate specification.

Public health relevance
Previously, we found that histones, key proteins that help specify cell fates, are segregated asymmetrically during the division of fruit fly germline stem cells. This asymmetry is initially established during DNA replication and we have found preliminary evidence that this difference is remarkably driven by varying the levels of key replication factors between cell types. Here we propose a series of experiments to test this model and ultimately elucidate the mechanism of this key pathway for cell fate specification.